Administration

Project Summary Administration Throughout the first cycle of CBORT operations, we have refined our administrative infrastructure to efficiently manage the integrated efforts of advancing OCT technology, providing services to a broad community of collaborators, and pursuing an effective agenda of training and dissemination. Our administrative aims remain to: 1. Establish and administer procedures to ensure the fluid integration of operations in TRDs, CPs, and SPs. 2. Facilitate training and dissemination broadly, across a varied spectrum of technical, pre-clinical, and clinical communities. 3. Ensure the responsible conduct of research and reporting under NIH and MGH institutional guidelines. CBORT resides within the Wellman Center for Photomedicine, one of five thematic centers of the Massachusetts General Hospital. Within CBORT, the administrative structure includes the Director, Brett E. Bouma, the Associate Director, Benjamin Vakoc, and the Resource Management Committee, comprising the leaders of the technical projects and training and dissemination initiatives. Scientific review of the research conducted within CBORT is facilitated by an annual meeting with an external advisory board.

Public health relevance
Project Narrative Administration The administrative structure of CBORT will ensure a fluid interaction between all components of the Resource, facilitate training and dissemination broadly and guarantee the responsible conduct of research and reporting.